Feasibility of Electronic Screening to Identify Risk of Opioid Misuse and Overdose

Program Summary/Abstract
From 1999–2020, more than 564,000 people died from an overdose involving any opioid, including prescription
and illicit opioids. Despite the decades-long nationwide effort to address opioid overdose in the United States,
we continue to see annual increases in opioid-related deaths. Prescription opioids are an entry point for over
75% of illicit drug users. Therefore, primary prevention is one of the four critical components of the U.S.
Department of Health & Human Services Overdose Prevention Strategy. The Food and Drug Administration
(FDA) has Risk Evaluation and Mitigation Strategy (REMS) for all opioids, although the current program has not
demonstrated significant benefits due to multiple factors including inconsistent delivery. ONE (Opioid and
Naloxone Education) is our innovative approach to screening and educating patients who receive prescribed
opioid medications. The program has been implemented in community pharmacies in three states and has
demonstrated positive outcomes including naloxone dispensing for high risk opioid prescriptions that is six times
the national average. Currently, the ONE program’s screening tool is paper-based, with the collected data
retrospectively entered into pharmacy computers. This proposal intends to integrate the tools and process
developed by the ONE Program into a digital platform on tablet PCs to improve the ability to consistently deliver
screening for opioid risk and provide targeted opioid safety interventions based on individual risk factors. Oprems
and North Dakota State University researchers will provide tablets with the digital platform to select community
pharmacy locations currently using the paper-based ONE screening tool. The tablet will collect additional
information on patient interaction with the digital screening tools, including the hesitation answering certain
questions, changed answers, and other variables which can be used to assess the functionality and validity of
the screening tools. These data will undergo statistical analysis to determine whether the digital platforms aid in
predicting potential opioid misuse and overdose and serve as another input to a robust screening process.
Concurrently, other predictive indicators for opioid misuse will be identified, including factors not currently
available, to support their assessment and to generate a longer-term target analytical model. The artificial
intelligence (AI) incorporated into the digital platform will be utilized to characterize patient actions and identify
patient behavioral characteristics that may indicate uncertainty, deceptive intent, or concern. Characteristics
associated with opioid misuse, overdose or overdose-related deaths will be used to identify the screening
elements with the most impact. Qualitative data gathered by surveys of pharmacy staff will be used to determine
how the digital platform fits into clinical workflow. Lastly, the digital platform will be compared to existing paper-
based ONE Program results to establish if there are significant differences in predictive efficacy. The research
will result in a consistent product suited for incorporation into FDA opioid REMS programs.

Public health relevance
Narrative The opioid crisis is a public health and economic crisis that is eroding the quality of life in the United States. ONE (Opioid and Naloxone Education) is our innovative approach to screening and educating patients who receive prescribed opioid medications at participating community pharmacies. This proposal intends to integrate the tools and process developed by the ONE Program into a digital platform to improve the ability to consistently deliver screening for opioid risk and provide education and interventions as part of an FDA opioid REMS program.